SCAN: Standardized Centralized Alzheimer's and Related Dementias Neuroimaging

PROJECT SUMMARY
This overall goal of this application is to create an infrastructure for supporting and augmenting neuroimaging
research in the National Institute of Aging’s Alzheimer’s Disease Centers (ADC) Program. The ADC program is
comprised of 30 centers that pursue research goals dedicated to increasing our understanding of Alzheimer’s
disease (AD) with a view towards improving diagnosis, care, and treatment of patients. Over the past decade,
neuroimaging has played an increasingly important role in this mission, as new approaches to measuring brain
structure, function, and biochemistry have produced biomarkers useful in diagnostic, mechanistic, and
therapeutic studies. At the same time, methods for standardization of neuroimaging have become accepted,
such that, despite the complexity and cost of imaging, we have the ability to combine images obtained at
different centers in order to answer important questions about AD that require large datasets. This project will
focus on standardizing approaches to magnetic resonance imaging (MRI) and positron emission tomography
(PET) images. MR standardization will address structural and functional (task-free) MRI, and PET
standardization will address amyloid, tau, and glucose metabolic imaging. We will work with the National
Alzheimer’s Coordinating Center (NACC) to develop protocols for securely uploading and de-identifying all
images at a NACC image repository, where a searchable database will also be available to researchers. We
will develop standards for MR and PET image acquisition, and make these imaging protocols available to the
ADC community. Uploaded images will undergo rigorous quality control and processing to permit merging of
images obtained on different platforms and, for PET, at different resolutions. Laboratories that have specialized
in image processing will produce numerical summary data of brain cerebrovascular pathology, brain volumes,
perfusion, diffusion, and cortical thickness, amyloid and tau deposition, and glucose metabolism. These
numerical variables will be stored at NACC where it will be linked to other ADC-related data on participants and
made available to researchers. Additional aspects of the program will include a website with documentation,
search functions, and user help functions. The administrative structure of the project will involve an executive
committee with membership from the participating laboratories as well as representation from the NACC, the
ADCs, and NIA. Leadership will remain apprised of changes in the neuroimaging landscape, and incorporate
new MR and PET measures as they develop with the overall goal of standardizing and disseminating agreed-
upon best practices while not stifling the development of new, innovative technical advances.

Public health relevance
PROJECT NARRATIVE The field of Alzheimer’s disease (AD) research has entered the era of “big data”, where large, multicenter data sets have contributed greatly to our understanding of the clinical variability, epidemiology, and genetics of the disease. This project will create an infrastructure for obtaining standardized brain images that can be combined across the 30 Alzheimer’s Disease Centers to create a very large database. Because imaging has become an integral part of the assessment of patients with AD, this work will advance our capabilities for performing high quality research on virtually any topic in this field that is related to brain imaging.